Discovering resistance-resistant antimalarial drug target

PROJECT SUMMARY/ABSTRACT
Malaria continues to be a major burden on global health, infecting over 220 million and killing over 400
thousand people annually. Although the past fifteen years of enhanced international efforts to eradicate
malaria has reduced malaria incidence worldwide, this progress has stagnated in recent years.
Antimalarial drugs are foundational in reducing disease and transmission, but resistance has developed
within twelve years of clinical introduction to every antimalarial drug developed since 1945 including
the current front-line artemisinin-based combination therapies. This ease with which parasites develop
resistance clearly indicates that innovative approaches to antimalarial drug discovery are urgently
needed. Here we propose two separate strategies designed to discover antimalarial drug targets for
which resistance will be difficult to develop in the field. The first approach will characterize metabolic
adaptations acquired by malaria parasites upon becoming resistant to a primary drug, with a focus on
identifying novel metabolic dependencies (vulnerabilities) of resistant parasites. We propose to employ
our extensive experience in metabolomic characterization of the malaria parasite, Plasmodium
falciparum, to compare drug-sensitive and drug-resistant parasite biochemical architectures.
Metabolomics will be used to elucidate altered metabolic pathways in resistant parasites in order to
reveal collateral sensitivities that we will validate as putative drug targets using either small molecule
pathway inhibitors or genetic knockdowns of relevant target enzymes. The ultimate goal will be to target
these collateral sensitivities together with the primary drug to lock the parasite into a drug-sensitive
state, as the adaptations required for primary resistance are no longer available, thus providing an
enduring, complementary combination therapy. For the second strategy, we propose to discover host
metabolic processes that are critical to support blood-stage development of P. falciparum. The blood
stages of the malaria parasite life cycle are responsible for both the symptomology and the human-to-
mosquito transmission of the parasite, and critically rely on nutrients from human serum. However, we
have found that different human serum lots are highly variable in their ability to support parasite growth
and transmission. To identify serum metabolites that correlate with parasite phenotypic readouts, we
propose to utilize our metabolomic approaches in combination with standard parasite growth and
transmission assays. Using serum lots from healthy donors, this approach will identify naturally
variable, and thus potentially targetable, host processes upon which the parasite is reliant. Targeting
host factors takes the evolutionary control away from the parasite, reducing the probability of resistance
emergence. In all, this proposal seeks to address the persistent problem of antimalarial drug resistance
development by evaluating two new strategies for discovering resistance-resistant drug targets.

Public health relevance
PROJECT NARATIVE: Although antimalarial drugs are critical for reducing disease incidence and transmission, resistance has emerged against every modern antimalarial drug within twelve years of clinical introduction, including to the current first-line artemisinin combination therapies (ACTs). This proposed study will apply two separate approaches to identify new drug targets for which parasite resistance would be unlikely to arise, opening new avenues for the development of long-lasting resistance-resistant antimalarial therapies. One approach will focus on identifying collateral sensitivities in parasites resistant to a wide range of drugs, while the second will identify host serum metabolites critical for asexual replication and production of transmission-competent Plasmodium falciparum parasites.